Develop a PET radiotracer suitable for in vivo imaging of TGFβ

Project Summary/Abstract
Transcription growth factor beta (TGFβ) is a pleiotropic cytokine with a significant role in creating an
immunosuppressive tumor microenvironment. High levels of TGFβ are strongly associated with poor cancer
prognosis, but there are currently no non-invasive methods available to quantify the cytokine in vivo. This
proposal describes the design and evaluation of a novel biologic positron emission tomography (PET) radiotracer
to selectively and quantitatively detect TGFβ in vivo. The proposed biologic construct is a recombinant protein
incorporating the extracellular domain of human TGFβ receptor II (TβRII) linked to the Fc fragment of human
IgG2 via the antibody hinge region. This recombinant protein was further modified by appending 1,4,7-
triazacyclononane-1,4,7-triacetic acid (NOTA) copper chelator via a p-SCN-Bn reactive moiety. The resulting
precursor molecule will be labeled with 64Cu to produce the active radiotracer, 64Cu-Fc:TβRII. The 64Cu-Fc:TβRII
radiotracer will be evaluated for preclinical efficacy by imaging mice using small animal PET-MRI. This proposal
aims to assess the efficacy of 64Cu-Fc:TβRII including a dose titration experiment to determine the optimal
dosage and incubation time for the radiotracer, a blocking study, a comparison of in vivo PET standardized
uptake values (SUVs) with ex vivo tumor lysate TGFβ concentrations in four murine tumor models, and an
experiment to detect changes in TGFβ expression before and after radiation therapy.

Public health relevance
Project Narrative High concentrations of the cytokine TGFβ in the tumor microenvironment contribute to cancer progression by facilitating tumor proliferation and metastasis while simultaneously inhibiting the function and differentiation of immune cells. Detecting and quantifying TGFβ in vivo would be a valuable diagnostic tool for clinicians as they assess treatment options and monitor patient responses to immunotherapy. The proposed 64Cu-Fc:TβRII PET radiotracer has the potential to fulfill this clinical unmet need.